Acquisition of a 900 MHz NMR Spectrometer Console and Probes

Funding is requested to obtain a Bruker Biospin NMR AVANCE Console and Probes to be installed on an existing Bruker Biospin 900 MHz NMR magnet system. The existing NMR console and probes are more than 14 years old and have reached the end of service lifetime, as designated by Bruker Biospin. The requested instrumentation provides enhanced sensitivity and capabilities for modern NMR experiments, including non-uniform sampling, complex waveform generation, and 1H magic- angle spinning solid-state NMR spectroscopy. The requested instrumentation is essential to the over- riding purpose of the New York Structural Biology Center (NYSBC), a consortium of nine research institutions in New York State, to support the particular aims of the NIH-funded research of the major and minor users of the spectrometer. Research conducted on the 900 MHz NMR Spectrometer ranges from fundamental studies of structure/function of biomolecules, to elucidation of mechanisms of pathogenesis, to discovery of novel lead compounds to pharmaceutical applications. The requested instrumentation will dramatically enhance the capacity of the 900 MHz NMR spectrometer to conduct this research.

Public health relevance
The New York Structural Biology Center (NYSBC), a consortium of nine research institutions in New York State, houses and supports ultra-high field (>600 MHz) NMR spectrometers used by scientists at member institutions. NMR spectroscopy is a critical method used across biological research conducted at member institutions. Maintaining state-of-the-art instrumentation is essential to the mission of NYSBC. The requested NMR console and probes will be installed on an existing 900 MHz NMR magnet system at NYSBC. The new instrumentation replaces obsolete instrumentation, provides new capabilities, and will enable research ranging from understanding fundamental biological processes in normal and pathological states to discovery of potential new drugs for treatment of cancer and other diseases.